Administrative Core

ABSTRACT – ADMINISTRATIVE CORE
The Administrative Core supports the CHIPTS mission by providing scientific guidance, administrative
leadership and program evaluation processes and leads all operational, dissemination, and key decision-
making functions for the entire center. The Administrative Core develops and implements the strategic plan. It
facilitates collaboration and fosters synergy across the cores and CHIPTS affiliated institutions; and it guides
CHIPTS' activities in global HIV prevention. The Administrative Core is led by the Senior Leadership Team:
Director Steve Shoptaw, PhD; Co-Director Raphael Landovitz, MD, MSc; Executive Director Uyen Kao, MPH.
The specific aims are: (1) Science: To provide scientific, programmatic, and administrative leadership to the
overall center; promote collaborative and multidisciplinary work among its scientists to advance the center's
mission; develop and implement the center's strategic plan; ensure scientific accountability using a continuous
quality improvement and evaluation process; and manage center's fiscal resources; (2) Networking: To
maintain the center's internal and external communication infrastructure to ensure effective dissemination and
sharing of information; coordinate its networking activities to foster synergy across its cores and promote
collaborations with other HIV-related centers, institutions, and partners; (3) Capacity Building: To coordinate
mentoring and training activities to increase the capacity of investigators, key community partners and
stakeholders to implement and scale-up high impact HIV prevention and treatment developments. The
Administrative Core monitors and ensures diversity, productivity and culturally competent leadership for all of
CHIPTS core directors and co-directors, ultimately measured by significance and innovation in contributions to
science, networking and capacity building. It disseminates information, leads interactions, and conducts
evaluation and quality improvement activities for the cores and the overall center. It houses all communications
between the Senior Leadership Team and therein brokers communication with the community and scientific
advisory boards, and the Core Committee, which is comprised of the core directors, co-directors and associate
directors from four other CHIPTS cores. Within the Administrative Core is the Global HIV Prevention Program.
This global program provides infrastructure support to CHIPTS investigators and their partners at international
institutions to create high-impact science agendas, especially in countries that have high HIV prevalence and
incidence, especially for populations with mental health and substance use disorders and barriers to social and
structural determinants of health that correspond with living with or at risk for HIV.